Core--FACS facility

Description (provided by applicant): The research plans of each of the subprojects have common themes that require flow cytometry on an intense and continual basis. The themes all relate to the control of tolerance and immunity in vivo at the level of DC function. All Projects will make regular use of the FACSCaliburs and FACSVantage analytical and sorting instruments. Optimal utilization of these instruments requires the services of a full-time research associate specialized in flow cytometry techniques. Salary for such a person is requested. The instruments themselves and physical facility have been purchased by either The Rockefeller University or The Howard Hughes Institute. Dr. Ralph Steinman will supervise this facility.